Intravital Microscopy Biomedical Resource Core

Project Summary/Abstract (Intravital Microscopy Biomedical Resource Core)
From its inception as an NIDDK-funded P50 Center in 2002, the mission of the Indiana O’Brien Center
for Advanced Renal Microscopy has been to provide renal researchers with effective access to advanced
forms of microscopy. Over the past 20 years of continuous funding, the IU O’Brien Center has pioneered the
development and dissemination of novel methods of multiphoton intravital microscopy that have been applied
in collaborative studies of renal physiology and pathophysiology with investigators from around the world. The
Intravital Microscopy Biomedical Resource Core will provide the renal research community with access to the
expertise and resources of the IU O’Brien Center to support intravital microscopy studies of the rat and mouse
kidney. The specific aims of the Intravital Microscopy Biomedical Resource Core are to (1) provide the renal
research community with expert intravital microscopy services to support quantitative studies of the physiology
and cell biology of mice and rats and (2) provide training in methods of intravital microscopy and image
analysis so that, wherever possible, investigators are capable of conducting intravital microscopy studies
independently at their home institutions.